INTEGRATED ENDURANCE AND RESISTANCE EXERCISE COUNTERMEASURES USING A GRAVITY IND

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. When astronauts are in space and therefore "weightless" many of their muscles are not used as much as on earth. This can lead to a loss of muscle size and strength as well as a decrease in their aerobic fitness. This loss of strength and fitness is a great concern for NASA (National Astronautics and Space Administration) and has prompted them to look for new exercise methods to counter this problem. In space the kinds of machines (or free weights) that are used on earth do not work due to the lack of gravity. NASA is considering using an new device that can be easily set up to use for strength training or aerobic cycling. This compact exercise device is called the flywheel exercise device and does not require gravity to work. Although we know from other studies that this device can maintain and even increase strength, no one has looked at the use of this device in a program that trains both the aerobic and strength systems in the body. In our first study we train people who are otherwise going about their normal activities. We would expect to see an increase in strength and an increase in their aerobic capacity (e.g., able to cycle longer or faster). We will compare this with other people who train using traditional exercise equipment normally used here on earth. This will tell us if the new device is as (or more) effective. The second study will involve people who walk on crutches to unload one of their legs. This is a model for what happens in space where the legs are not needed for support. As in the first study, these subjects will train using either the new device or traditional exercise machines to see if the new device can prevent loss of strength and aerobic fitness. The results of these studies will validate the use of this new exercise machine for both strength training and aerobic physical fitness for possible use on future long term space flights.